Effects of Heat Exposure on Maternal and Pregnancy Health: Understanding the Role of Social Determinants and Adaptive Behaviors

ABSTRACT
Climate change, exacerbated by urbanization, is escalating extreme heat globally, posing significant threats to
human health, particularly among vulnerable demographic groups. This study addresses critical gaps in
understanding daily heat exposure of vulnerable urban residents, specifically pregnant women. While previous
research has linked increased temperatures to adverse pregnancy outcomes, this study aims to extend that work
in order to unravel complex interactions between hyperlocal (neighborhood) heat exposure, social determinants
of health (SDoH), and adaptive behaviors among pregnant women in Miami, Florida. Epidemiological evidence
underscores associations between extreme heat exposure and negative pregnancy-related outcomes. Census
data, typically used in existing studies, overlooks hyperlocal heat conditions such as indoor/outdoor home
temperatures and neighborhood temperature. Miami's temperatures often exceed official National Weather
Service measurements. Leveraging hyperlocal assessments, this study investigates the effects of this extreme
heat on maternal and pregnancy health outcomes. The proposed longitudinal pilot study, embedded in an
established pregnancy cohort, aims to achieve two specific aims. The first aim seeks to examine the moderating
role of SDoH (e.g., neighborhood/housing quality, and economic hardship) on the interactions between heat
exposure and maternal/pregnancy health outcomes (psychological stress, low birth weight, and preterm birth.)
The hypothesis posits that higher hyperlocal heat exposure will be associated with poorer neighborhood/housing
quality and greater economic hardship and will negatively affect maternal and pregnancy health outcomes. The
second aim focuses on identifying heat adaptive behaviors (e.g. HVAC usage, decreased step count) adopted
by pregnant women to mitigate the risks of heat exposure in context of SDoH. The hypothesis suggests that heat
adaptive behaviors, such as reduced step count in warmer months and increased air-conditioning use, will
mitigate the risks of heat exposure. This study contributes to the understanding of local heat exposure effects
on pregnancy, emphasizing the need for effective and equitable adaptations. By aligning with the Social
Determinants of Health framework and the National Institute of Nursing Research's strategic plan, this research
aims to inform future interventions and policies. The proposed F31 award provides the researcher with
opportunity to develop essential skills in both maternal health and climate health research, paving the way for
future postdoctoral opportunities and a career as an independent nurse researcher.

Public health relevance
PROJECT NARRATIVE Climate change, exacerbated by urbanization, is escalating extreme heat events globally, posing significant threats to human health. This longitudinal pilot study based in Miami, Florida investigates the effects of local heat exposure among vulnerable populations, specifically on maternal and pregnancy health, and women’s adaptive behaviors. By analyzing hyperlocal heat assessments and interactions with SDoH, this research aims to inform effective and equitable adaptations to mitigate the risks of heat during pregnancy.